Enrichment Program

ENRICHMENT PROGRAM: PROGRAM SUMMARY / ABSTRACT
The Georgia Center for Diabetes Translation Research (GCDTR) Enrichment Program serves a critical role,
facilitating a culture of diabetes translation research and promoting cohesion and collaboration across center
collaborating institutions (Emory University, Morehouse School of Medicine, Georgia Institute of Technology),
community and institutional partners in Atlanta, Georgia and the Southeastern region (specifically, Florida and
Tennessee). The Enrichment Program will orchestrate a broad range of educational and dissemination activities
and serve as a focal point for interaction and collaboration among GCDTR Core Experts and members of all
affiliations (local, state, and regional partner institutions). The Enrichment Program will be closely integrated with
the Pilot and Feasibility (P&F) Program and the GCDTR Cores (Core B: Design and Evaluation for Equity; Core
C: Socioecological and Behavioral Sciences for Equity; and the Regional Core: Technologies Advancing
Translation and Equity). The Enrichment Program will plan programming and mentoring opportunities that
coordinate with, bolster, and align with Core and P&F aims, providing a channel to share opportunities, link
collaborators, and develop skills, especially for junior and underrepresented minority (URM) investigators. The
Enrichment Program will invite diverse academic leaders across GCDTR institutions to contribute to educational
programs to keep researchers abreast of the latest developments in the field of diabetes translation research
(relevant to the Cores) and create a network to facilitate cross-disciplinary collaborative projects for junior
investigators. The program will leverage the GCDTR's extensive networks to invite visiting lectures from national
and international leaders in the field. The Enrichment Program's specific aims are to 1) create an educational and
academic environment to support innovative type 2 translation research, linked to the Cores, at our Atlanta-based
and regional partner institutions; 2) disseminate the latest knowledge in diabetes translation research and build
stronger statewide, regional, and academic-community partnerships; 3) support the expansion of junior and URM
faculty working and thriving in the field of diabetes translation research trough the formation of small, mentor-
guided, peer working groups; and 4) regularly evaluate and update programming to meet the needs of users.
Enrichment Program innovations include expanding access to programming to regional, community, and other
partners; an Enrichment Planning Committee made up of primarily junior researchers; a formal peer mentoring
program for junior researchers; and targeted efforts to promote diversity and equity in program offerings, faculty
development, and diabetes translation research. Dr. Guillermo Umpierrez (Emory School of Medicine) and Dr.
Mary Beth Weber (Emory Rollins School of Public Health) will direct the Enrichment Program, coordinating with
the Cores and P&F through the GCDTR Executive Council, to facilitate and encourage the participation of an
outstanding multi-disciplinary team of experienced clinical researchers and educators.